Training in Developmental Hematology

PROJECT SUMMARY/ABSTRACT
Studies in pediatric blood disorders provide an important paradigm for understanding the fundamental
mechanisms regulating hematopoiesis. Unlike adult hematologic disorders, many pediatric diseases result
from intrinsic genetic defects that control blood cell development or function. Understanding remains
incomplete on the molecular pathogenesis of most of the hematologic diseases in children. At UCLA, we have
a tremendous resource of interdisciplinary investigators whose research focuses on a wide spectrum of topics
related to developmental hematology. Given the declining number of physician-scientists in Pediatric
Hematology, a training program in Developmental Hematology is critical to produce the cadre of investigators
who will continue to advance the field. Therefore, we propose a unique training program that focuses
specifically on pediatric hematologic diseases by integrating a variety of disciplines, including molecular and
cellular hematopoiesis, alternative organism models, stem cell transplantation and gene therapy, hemostasis
and thrombosis, transfusion medicine, novel technologies (genomics, proteomics, gene editing, etc.),
hematologic malignancies, therapeutics, and bioinformatics. In this application, we seek funding for 4
postdoctoral fellows per year for 5 years. The fellows will be either recent recipients of MD, MD/PhD, or PhD
degrees undergoing postdoctoral training. We will emphasize recruitment to reflect the gender, racial, and
ethnic diversity of our nation. Trainees will have the opportunity to develop research in one of the 22 faculty
member's laboratories that bridge 12 Departments, providing trainees access to the incredibly diverse
academic assets across the UCLA campus. The mentoring faculty have active and productive research
programs and multiple mutual collaborations and publications, providing an ideal training environment.
Trainees may also participate in an exchange program established with the NHLBI-funded T32 program at the
University of Michigan (HL007622) to gain deeper knowledge of either hemostasis/thrombosis or
hematopoietic stem cell transplantation, two academic strengths of their program (UM trainees may come to
UCLA for training in cell and gene therapy). Trainees will be selected from a large pool of postdoctoral fellows
based on their academic and research achievements. Appointments will be for 1-2 years, the second year
appointment dependent on documented productivity. Trainees will take a required course on Developmental
Hematology and receive training in principles of human subject research and the responsible conduct of
research through courses in research ethics. They will participate in journal clubs and attend seminars and
lectures related to pediatric hematology, stem cell biology, immunology and clinical research. Trainees will
meet with a Scholarship Oversight Committee every 6 months to monitor progress and productivity. We will
utilize the strengths of UCLA, including the breadth and depth of investigators across many disciplines, to train
future researchers and leaders in the field of Pediatric Hematology.

Public health relevance
PROJECT NARRATIVE The goal of the Training in Developmental hematology Program is to train postdoctoral fellows in innovative basic, translational, and clinical research. Training future leaders and researchers in the field of Pediatric Hematology will advance our knowledge of Pediatric Hematologic diseases. This new understanding will lead to improved treatment and overall quality of life for children (and adults) with blood diseases.